Function of Sequence-specific RNA Binding Proteins

Summary
Alternative splicing is nearly universal in human genes, producing multiple distinct mRNAs and proteins from
each individual gene locus. This process is regulated by over one hundred splicing factors that bind to specific
RNA motifs in the primary transcript and modulate splicing by interaction with core splicing machinery or with
other splicing factors. This proposal seeks to understand the rules that govern the activities of splicing factors.
Each splicing factor's activity can be summarized by an RNA map that describes how its activity depends on
location of binding relative to the regulated exon or splice sites. It is organized around the following aims.
SA1. To develop and test second-generation (2G) “RNA Maps” describing splicing factor activity
SA2. To understand the protein sequence determinants of splicing regulatory activity and improve RNA
maps using engineered splicing factors
SA3. To improve RNA maps by incorporating indirect and interaction effects
In Aim 1, we will develop models that distinguish notions of “affinity”, “binding”, “location”, and “regulatory
activity”, and will develop software to generate 2G RNA maps from different combinations of data types,
including in vitro and/or in vivo binding data and RNA sequencing data, and will extend these maps to several
types of RNA processing events. In Aim 2 we will identify protein sequence features that confer different types
of splicing regulation, and will engineer “hyperactive” splicing factors to produce larger splicing changes and
improve functional inference. Finally, we will dissect direct regulation by a factor from indirect regulation
– where one splicing factor regulates another that directly regulates the splicing of other genes – and will also
consider how splicing factors may cooperate or antagonize one another's regulatory activity. Together, these
studies will improve our understanding of how RNA splicing factors work, enabling improved understanding of
disease states where splicing factors are mutated (including many blood cancers), and improved prediction of
the effects of sequence variants in the human genome that cause disease by altering splicing factor binding
sites in exons and introns.

Public health relevance
Project Narrative This project seeks to understand and establish predictive rules for how the alternative splicing of human genes is regulated by splicing factor proteins. These studies will aid in understanding the effects of mutations in splicing factors that occur commonly in blood cancers, and in predicting the effects of sequence variants in the human genome that may cause disease by altering the binding sites of splicing factors in exons and introns.